Characterization of Human MafA/B Activity in Pancreatic Beta Cells

? DESCRIPTION (provided by applicant): The hallmark of diabetes mellitus is glucose imbalance caused by the loss and/or dysfunction of the pancreatic β-cell. Current research is focused on retaining/replacing the function of the pancreatic β-cell mass. The molecular mechanisms that govern islet β-cell development, maintenance, and function often involve the actions of transcription factors. The Stein lab and others have identified the large Maf proteins, MafA and MafB, as crucial regulators of β-cell development and function. These transcription factors bind to cis-acting enhancer sequences as either homodimers (MafA2, MafB2) or heterodimers (MafA/B) and subsequently recruit coregulatory trans-acting factors. These coregulators modulate transcription through reorganization of nucleosomes and modification of histones and the basal transcription machinery. Rodents exclusively express MafA in mature β-cells, while humans express both MafA and MafB. Unfortunately, little information exists concerning the function of MafA/B compared to MafA2 and MafB2 in adult human β-cells. I have generated a mouse model (MafBtg) that misexpresses MafB in the mature β-cell, mimicking the human adult β-cell. I have validated the sequence integrity, molecular weight, and distribution pattern of the MafB transgene, as well as established the existence of the MafA/B heterodimer in MafBtg islets. In Aim 1, I will examine the molecular consequences of MafA/B on islet β-cell activity. Preliminary data suggests that the roles of MafA2 and MafA/B overlap, given that MafBtg animals exhibit normal glucose clearance when challenged with glucose. Gene expression analysis (qPCR), MafA/B promoter occupancy (re-ChIP), and perifusion analysis (GSIS) will be performed in MafBtg islets to further examine the role of MafA/MafB. Although MafA and MafB share similar structures, they exhibit distinct functional characteristics. In Aim 2, I will investigate similarities and differences between MafA2 and MafB2 in adult β-cells by crossing MafBtg animals with animals devoid of MafA expression in β-cells (MafA??), a model that mimics the juvenile human β-cell. Preliminary results have revealed that MafB does not rescue glucose intolerance in the MafA?? background. Techniques used in Aim 1 will be utilized to delineate the role of MafB2 in comparison to MafA2 and MafA/B. MafA and MafB transcriptional activities may not be equivalent due to a divergent recruitment of distinct coregulators. Coregulators of MafA/B and MafB2 will be identified in Aim 3 by using a reversible in-cell cross-link immunoprecipitation (Re-CLIP), mass spectrometry (MS) strategy in EndoC-βH1 cells, a newly characterized human β-cell line that express both MafA and MafB. Candidate coregulators will be tested in co-IP, re-ChIP and proximity ligation assays (PLAs) for validation. Collectively, this proposal aims to identify the significance of MafB2 and MafA/B in islet functions and coregulators essential for their transcriptional regulation. Knowledge gained from this proposal will significantly enhance our understanding of the molecular details underlying the human β-cell and will be useful toward the efforts of generating/retaining β-cells for the treatment of diabetes.

Public health relevance
PUBLIC HEALTH RELEVANCE: In this proposal, the function of the MafA/B heterodimer that exists in human adult β-cells will be tested in a mouse model that mimics human β-cells (MafBtg) and the human β-cell line (EndoC-βH1). Pancreatic islet β- cells and EndoC-βH1 cells will be subjected to molecular- and physiological-based assays to delineate distinctions in gene targets and coregulators between MafA2 (found in rodent adult β-cells), MafB2 (found in human juvenile β-cells) and MafA/B (found in human adult β-cells). Together, these data will demonstrate the importance MafA/B and MafB2 and the mechanism of action by which these factors regulate and maintain human adult β-cell function.